Wood Pellet Emissions and Children's Environmental Health in Mississippi

Abstract
Children living near industrial activities are at a heightened risk of poorer health, including stress, asthma, and
other respiratory illnesses. An increased understanding of climate change along with the results of prior studies
linking adverse health effects to fossil fuel activities have precipitated a shift towards alternative energy
sources such as wood biomass. As a result, the market for wood pellets is booming, and plants are springing
up across the US, especially in the deep south. Wood pellet plants are twice as likely to be in predominantly
Black communities that are additionally burdened with many health, social, economic, and infrastructural
disparities. Despite growing community concerns about environmental health impacts on communities
surrounding wood pellet plants, few studies have been conducted. Epidemiologic studies suggest that living
nearby industrial manufacturing, generally, and wood-related manufacturing, specifically, is associated with
negative respiratory health and psychological distress in children. However, these studies are limited due to
their inability to holistically characterize the pollutants emitted from wood pellet production when assessing
pediatric health impacts. We are proposing a place-based study in Mississippi–the least healthy state
regarding childhood respiratory diseases as 1 in every 10 children under the age of 18 has asthma, and 3.3%
more Black children than White children have asthma. Mississippi also has 7 wood pellet plants-4 fully
operational and 3 soon to be open (or in early development) that are anticipated to be the largest plants in the
world. Preliminary exposure data suggests that communities with active wood pellet plants have higher air and
sound levels than communities without active plants. Our research goals are to build on this preliminary data
and carry out an extensive air and noise pollution exposure assessment in three types of communities: t those
with an operational wood pellet plant, those with a proposed wood pellet plant, and those with no wood pellet
plants and no (or limited) other industrial manufacturing. We propose to conduct a combined ambient and
indoor sound and air pollution assessment (Aim 1 and Exploratory Aim) and will use these measurements to
assess their impact on children’s respiratory health and stress, also examining the extent to which
neighborhood resources, community stressors, and structural factors may modify these associations (Aim 2).
We will also invest in local human capital and engage the community by providing research training for
Mississippi-based high school students, community college students, undergraduate students, graduate
students, and older adults; community engagement activities using our app, NoiseScore; and environmental-
literacy tools using our activity book series. We will create a cohort of local researchers and concerned
residents who will become first-authors in their future stories. Together, we can develop strategies, policies,
and interventions to improve community health and well-being.

Public health relevance
Narrative Given the desire to move from fossil fuels to renewable energy sources, the market for wood pellets is booming, and wood pellet production plants are rapidly sprouting up across the United States, most notably in predominantly black and poor communities in the deep south. Taking advantage of the staggered opening of wood pellet production plants in Mississippi--a state also grappling with significant pediatric health and quality of life issues, this project will measure and model the propagation of both air and noise pollution from wood pellet production into the surrounding community and will examine how and to what extent these wood pellet production exposures impact the health and well-being of children living nearby. Understanding how multiple physical and chemical environmental exposures impact children’s respiratory and stress health will reveal key insights that can help us better assess economic benefits against environmental health costs of wood pellet production as an alternative energy source and investing in local human capital will create a cohort of diverse, local researchers and concerned residents who will become first-authors in their future stories.